A randomized controlled trial of a Multi-component family Intervention to Lower depression and Address intimate Partner violence (MILAP) among young women in Nepal

PROJECT SUMMARY
Intimate Partner Violence (IPV) is a major public health problem in low- and middle-income countries
(LMICs). Globally, an estimated 30% of women report physical or sexual violence by an intimate partner in
their lifetime. IPV is a well-established social driver of mental health problems and doubles the rate of
depression and PTSD. Interventions like cognitive behavioral therapy (CBT) can improve depression after
women experiencing IPV exit abusive relationships. However, despite ongoing violence, many young women
in LMICs are less likely to divorce or separate from their husband. But ongoing IPV severely limits mental
health recovery and increases the risks of suicide. Another important factor in many LMICs is that young
women often live in extended, multi-generational households, where studies have shown that mother-in-laws
(MILs) play a critical role in young daughter-in-laws (DILs) autonomy and freedom of movement, substantially
affecting her mental health. The pathways via which multiple family members and ongoing IPV affect young
women’s mental health in LMICs is very poorly understood. There is an urgent need to study interventions
that: a) improve mental health and reduce IPV; b) engage husbands and MILs, and not just women
experiencing IPV; and c) elucidate pathways via which IPV-related drivers affect mental health. Our Nepal-
US collaborative team has pilot-tested a novel Multi-component family Intervention to Lower depression and
Address intimate Partner violence (MILAP, meaning unity and reconciliation in Nepali) among young women
in Nepal. MILAP’s first component engages DILs and their MILs by establishing them as allies in addressing
IPV and improving DIL’s empowerment and freedom of movement. In MILAP’s second component, the DIL
and her husband participate in behavioral couple’s therapy (BCT) to improve communication skills, increase
caring behaviors, and enhance trust in the marital relationship. This approach was acceptable, feasible, and
safe. It resulted in substantial reduction in proportion of people with moderate depression (PHQ-9>9)
(baseline: 46%, 3 months: 4%). Based on this pilot study (n=75; 25 triads), we now propose to conduct a fully-
powered RCT of MILAP to: a) establish effectiveness by conducting a 12-month RCT with 300 triads (young
women reporting IPV, their husbands, and their MILs), b) understand mechanism of intervention impact, and c)
conduct a costing analysis.
Our team has a 16-year history of successful global health collaborative research in Nepal. If
successful, this study will deliver an effective family intervention and a better understanding of its
mechanism to address two complex challenges (IPV and depression) that lead to a massive public health
burden among young women living in Nepal, other LMICs, and other regions where women live in multi-
generational households and have limited options to leave abusive relationships.

Public health relevance
Project Narrative Intimate Partner Violence (IPV) is a major global problem that can lead to mental health problems such as depression and PTSD. We propose to test a family-based intervention, Multi-component family Intervention to Lower depression and Address intimate Partner violence (MILAP), that will engage women experiencing IPV, their husbands, and mothers-in-law. If successful, the results of this study can provide an intervention that will improve depression, address IPV, and reduce PTSD, and help us understand the mechanisms via which this intervention works.